Pathophysiology of Myotonia and Periodic Paralysis

Project Summary / Abstract
Periodic paralysis and myotonia are ion channelopathies of skeletal muscle with debilitating episodes of severe
weakness lasting hours to days and activity-dependent muscle stiffness. The long-term goal of this project is to
advance our understanding of disease mechanism in these disorders of muscle excitability and to apply this
knowledge in the design and pre-clinical testing of therapeutic interventions.
Much progress has been made in establishing a causal relationship between the biophysical defect of a
mutant channel and the clinical phenotype. For example, over 80 missense mutations have been identified in
the NaV1.4 sodium channel, and we have shown by functional expression studies, coupled with simulations of
fiber excitability, that mutations with gain of function changes (e.g. impaired inactivation) cause hyperkalemic
periodic paralysis (HyperPP) with myotonia. Alternatively, the NaV1.4 mutations in hypokalemic periodic
paralysis (HypoPP) are all R/X substitutions in S4 segments of voltage sensor domains that share a common
functional defect - the anomalous gating pore leakage current. In all forms of periodic paralysis, the transient
attacks of weakness result from sustained depolarization of 𝑉𝑟𝑒௦௧ and loss of excitability, which are often triggered
by stress, diet (carbohydrate, salt content, fasting), cold temperature, or exercise. The mechanisms by which
these triggers destabilize 𝑉𝑟𝑒௦௧, in the setting of a static defect for a mutant channel, are fundamental open
questions in the field and also represent opportunities for therapeutic intervention. A major impediment to
progress has been the scarce availability of affected muscle. We created three knock-in mutant mouse models
of PP that have robust phenotypes for HyperPP (NaV1.4-M1592V) or HypoPP (NaV1.4-R669H; CaV1.1-R528H).
These mouse models have led to new insights on disease mechanism (e.g. recovery from acidosis is a potent
trigger of HypoPP) and have led to novel therapeutic interventions that are now in clinical trials (bumetanide
inhibition of the NKCC1 cotransporter prevents HypoPP).
We will extend our investigations of periodic paralysis by focusing on the impact of ion gradients.
Changes in extracellular [K+]o are established triggers for HypoPP (low) or HyperPP (high), but relatively little is
known about Na+ and Cl- shifts in PP. Limited human data suggest an acute rise of [Na+]in during an episode of
HyperPP or chronically high [Na+]in for HypoPP. In addition, we showed that reducing Cl- influx completely
prevents HypoPP attacks. We have developed improved ion-selective microelectrodes, that in combination with
the unique resource of our knock-in mutant mice, will enable us to (1) characterize muscle fiber Na+ and Cl-
content at rest and during an attack of PP, (2) define the contribution of specific ion transport systems (mutant
NaV1.4, NKCC1, Na/K-ATPase, Cl- exchangers) in setting ion concentrations in muscle channelopathies, (3)
define the functional consequences of ion gradient perturbations in PP, based on computational modeling and
simulation, and (4) use these insights in the design and pre-clinical testing of disease-modifying interventions.
.

Public health relevance
Periodic paralysis is a rare inherited disorder of skeletal muscle in which recurrent episodes of severe weakness, and the risk of progressive weakness with loss of ambulation, are caused by mutations of ion channel genes. The defects in channel function resulting from these mutations are now known, but the mechanism by which transient attacks of paralysis are triggered by diet, stress, or exercise are poorly understood. We will use our genetically-engineered mouse models of periodic paralysis to explore the hypothesis that these transient episodes of weakness occur as a result of changes in the abundance of intracellular ions (sodium and chloride), and also determine whether channel defects lead to chronically altered intracellular ion content.